Administration Core

ABSTRACT – ADMINISTRATIVE CORE
The epidemic of youth vaping is threatening the health and well-being of adolescents. The proposed project (“A
Multidisciplinary Assessment of Risks of Vaping in Early Life” - Project MARVEL) takes an integrated
multidisciplinary approach to assess the impact of youth vaping on health in collaboration with the system that
is most directly impacted by adolescent vaping and is well-positioned to intervene to reduce the potential
negative health impact - schools. To achieve this overarching goal, Project MARVEL brings together expertise
in adolescent development, addiction, tobacco regulatory science, longitudinal research methods, brain
development, respiratory health, biomarkers, multi-omics, biostatistics, community engagement, and health
communication. Project MARVEL includes four innovative and integrative projects that will determine the
impact of vaping on dependence and well-being (Project 1), brain health and cognitive and psychosocial
development (Project 2), and respiratory health (Project 3), and leverage this health information, along with the
extant literature to develop health communication messages focused on how vaping affects adolescents’
health and lives now (Project 4). These projects are supported by four cores that provide critical services
including: (1) administrative support; (2) biostatistical expertise; (3) facilitation with conducting research with
adolescents, including recruitment and retention; and (4) biomarkers of exposure/effect, and measurement of
product constituents, generated aerosols. Conducting the type of translational and participatory adolescent
research proposed in Project MARVEL is challenging. It requires oversight of large and complex projects and
cores, coordination between researchers; facilitation of scientific integration across different disciplines; and
the experience required to overcome many practical challenges to the successful implementation of scientific
protocols. The Administrative Core was designed to address each of these challenges through three specific
aims: 1) Manage operations including administrative, financial, and regulatory functions; 2) Facilitate scientific
discussion, and integration; 3) Coordinate dissemination of scientific findings. To address these aims, the
Administrative Core will oversee regular meetings, organize travel and reimbursements; provide budgetary
oversight for all projects and cores; and oversee human subjects’ protections, registration of clinical trials, and
the generation of reports. The Administrative Core will also organize regular discussion of topics related to
youth vaping through a monthly scientific seminar and an annual scientific retreat/external advisory board
meeting, support the development of scientific presentations, manuscripts, and submissions to the federal
docket, and implement policies for data sharing across the three research projects, as well as external to the
Program Project. Lastly, the Administrative Core will engage experts to serve on an External Advisory Board to
review the immediate and long-term goals of MARVEL, to monitor progress towards these goals, and to
provide input on study design study design, interpretation of results, and translational efforts.

Public health relevance
NARRATIVE – ADMINISTRATIVE CORE Project MARVEL takes a multidisciplinary approach to assess the impact of youth vaping on health with projects that address vaping behavior, dependence, well-being, brain health and cognitive and psychosocial development, respiratory health, and how to inform adolescents about the effects of vaping. Conducting the type of translational and participatory adolescent research proposed in Project MARVEL is challenging. The Administrative Core will address these challenges by managing operations; facilitating scientific discussion, and integration; and supporting dissemination.